Strengthening national food safety system by improving veterinary diagnostics

Project Summary
The safety of the United States food supply system can be enhanced by research and capacity
building during case investigations, including chemical, microbiological, pathological, or other
complex analyses to help determine cases of potential adulteration or contamination of animal
foods or animal drugs. This project seeks to enhance the veterinary diagnostic capacity of Animal
Disease Research and Diagnostic Laboratory (ADRDL), South Dakota by; (1) surveillance of
animal food and veterinary infections, (2) increasing animal pathogen typing and tracking capacity
through whole genome sequencing based testing, (3) coordinating with other veterinary
diagnostic laboratories to improve the national food safety system by supporting research and
capacity building during case investigations, (4) maintaining accreditation (AAVLD, ISO/IEC
17025) or adopt other quality system comparable to international standards, and (5) supporting
training, quality assurance processes, proficiency exercises, and data sharing to support
development of veterinary diagnostic laboratories.

Public health relevance
Project Narrative This goal of this application is to enhance the veterinary diagnostic capacity and capabilities of Animal Disease Research and Diagnostic Laboratory (ADRDL), South Dakota in support of improving the national food safety system. This project will allow ADRDL to participate in Veterinary Laboratory Investigation and Response Network (Vet-LIRN). Through this program, ADRDL will serve as a regional sequencing lab and also will perform diagnostic testing as required by Vet-LIRN.